ALS Efficiently Networking Advanced Beam Line Experiments (ALS-ENABLE)

OverSaulmlmary/Abstract Theovergaolaollfthpirsopoisstaoplrovainidnetegreafftiecsdiy,enncthrsottrruocbntiuorlRaoelgsyoutroce threeseacrocmhmunTihtiRyse.soucracleAl,LeSd-ENAwBiLblEel,locaatttehdAedvanLciegdShoturce (ALiSnB)erkeley, thmeatusrterucbtiuorlaolgy techn ICwtaiplrilofvoaitrdrneainas.parent interface to atthAeLSa,nbdedesigtnooepdtimtihczeheancoefssuccestsrfucldteutreermifnobarottirhonutainnde challepnrgoibnlgMeumlst.aicpcleemseschaniisnmcsl,uodnsiintrgee,momtaei,la-nicdnollabowribaletlive proviadnedtdh,uesewrisblelguidtehdrotuhgmehosatpproprroiuatfteoeasrnswertihnebgiirologic questTihoeRne.souwricleelvertahgseeubstantialinconstrauncdtoipoenratbiyootnhser investment fundaignegnciinedsu,asntdraycademTihaeR.esouhracs3eTechnoOlpoegryatCioorne(ssTOCtsh)at addrsepsescniefeidicsnthreeseacrocmhmun1i)rtayp:riedspocnrsyestall2o)hgirgqahupahlayin,thdyigh througshmpaualtnlglXe-rsacyattearnid3n)sgp,eciaclriyzsetdallAomgurlatpihfyta.rcaeitaneniddng outreparcohgrwaiimlnlcorpfoarcaet-ettor-afiarnceiemnogat,nedonlimnaeterainadtlrsa,ignrionugTphse. Resouwrichlealvaerobuwsetbpresebnecree,presienpneteerd-repvuibelwiecdantdipoanrst,iciinpat profesmseieotniaanlngdwsorkshtoopprsomoAtLeS-ENAcBaLpEabirleictrniueiwsut,serasn,dreport ResoutreccehnoltotghigeerseastterrucbtiuorlacologmymunTihteRye.souwricbleelmanagbeydan adminisctorraweth,iivcwehielnlsutrhealtocraelm,oatned,collaboarcacteiissmvsaeintafionpreder­ reviewed Baseodnevaluoaftmieotnraincudssefreedbwaecwkic,lolnsisitmepnrtolvye beamtime proposals. thueseirnteratchtriootunhgAsehLS-ENAwBeLbpEoratnatdlheexperimrenstoaulrces.

Public health relevance
Project Narrative - Overall X-ray crystallography and solution scattering are critical tools in the study of biological systems. They are able to provide information that has been a prerequisite to the understanding the fundamentals of life. They are also methods that have proved themselves to be central to the development of new therapeutics for human disease. The overarching goal of this proposal is to provide an integrated synchrotron Resource that makes mature technologies for crystallography and small angle X-ray scattering available to a broad research community. This will lead to more insightful biological interpretation and better drugs to improve human health.